PRIDE Academy: Impact of Ancestry and Gender to omics of lung diseases

PROJECT ABSTRACT
This is a new application for a “PRIDE Academy: Impact of Ancestry and Gender on omics of lung
diseases” whose objective is to introduce scholars from under-represented backgrounds to omics of lung
diseases with a focus on how datasets should be interpreted and applied when working with under-represented
populations. This academy will be housed at the Pulmonary and Biomedical Informatics and Personalized
Medicine (BiPM) Divisions at Anschutz Medical Campus in Colorado. The Pulmonary Division has a
distinguished historical record of training leaders in pulmonary medicine and the relatively new BiPM Division
has been instrumental in elucidating to what extent genetics can explain health disparities in complex diseases,
particularly asthma. We propose a PRIDE summer academy that will include didactic and hands-on workshops
in genomics and proteomics of lung diseases such as asthma, emphysema, pulmonary fibrosis, and pulmonary
hypertension. The PRIDE scholars will be assigned a mentoring team closely aligned with the mentees’ research
interests. Here, in addition to the usual didactic and hands-on activities, we propose an additional level of
training that uses the concept of academic “coaches”. A coach is not intended to supplant the mentor, but rather
complement this relationship, since coaches do not interact with the scholars one-on-one but rather as a group.
The coach will guide team members through the process of successfully navigating the academic world using
well-tested social science approaches. The overall objectives are to select talented underrepresented junior
faculty scholars with a demonstrated interest in pulmonary diseases; introduce the scholars to a toolkit including
a mentoring team, instruction on “omics” of cardio-pulmonary diseases and a suite of social science theories for
academic persistence; pair coaches with scholars to ensure that all the milestones are achieved; provide
scholars with grant-writing workshops and mock study sections that will position them to compete for intramural
and extramural grants; implement an evaluation plan that measures the degree to which the program is achieving
its objectives. Scholars will travel to Denver for the PRIDE summer academies for 2 consecutive years and to
Aspen for a face-to-face mid-year meeting at the Annual Tom Petty Aspen Lung Conference. By using the
combination of coaching and social science practices such as cultural capital and communities of practice that
allow team members to feel connected with each other, and pairing the scholars with distinguished pulmonary
and BiPM faculty mentors, we will ensure their academic persistence and ultimate success.

Public health relevance
PROJECT NARRATIVE This “PRIDE Academy: Impact of Ancestry and Gender on omics of lung diseases” will select junior faculty scholars from under-represented groups and bring them for a summer academy at the University of Colorado Anschutz Medical Campus. Here, the scholars will be introduced to state-of-the-art approaches and methodology to study the impact of ancestry and gender on lung diseases such as emphysema, asthma and pulmonary hypertension. Scholars will be mentored by experts in personalized medicine and pulmonary fields. In addition, the scholars will participate in career development activities and will be introduced to the concept of academic coaches who will employ social science approaches to ensure scholars’ long-term academic persistence. Our overall goal is to create a workforce of pulmonary researchers who are as diverse as the community they serve.